IGF::OT::IGF Applied Research Program (ARP) Meeting and Working Group Support-Option Period 3CISNET 2017 Annual Meeting- October 30th-3rd POP September 14th, 2017 through Nov 30, 2017

Applied Research Program (ARP) Meeting and Working Group Support-Option Period 3CISNET 2017 Annual Meeting